The Healthy Brain and Child Development National Consortium Administrative Core

Neurodevelopmental processes are shaped by dynamic interactions between genes and environments. Maladaptive experiences early in life can alter developmental trajectories, leading to harmful and enduring developmental sequelae. Pre- and postnatal hazards include maternal substance exposure, toxicant exposures in pregnancy and early life, maternal health conditions, parental psychopathology, maltreatment, and excessive stress. To elucidate how various environmental hazards impact child development, it is imperative that a normative template of developmental trajectories over the first 10 years of life be established based on a sufficiently large and demographically heterogeneous sample of the United States (US) population. To accomplish this, the Healthy Brain and Child Development (HBCD) Consortium under the leadership and management of the HBCD Consortium Administrative Core (HCAC) will deploy a harmonized, optimized, and innovative set of neuroimaging (MRI, EEG) measures complemented by an extensive battery of behavioral, physiological, and psychological tools, and biospecimens to understand neurodevelopmental trajectories in a sample of 7,200 mothers and infants enrolled at 27 sites across the US. The overarching goal of the HBCD Study is to create a comprehensive, harmonized, and high-dimensional dataset that will characterize typical neurodevelopmental trajectories in US children and that will assess how biological and environmental exposures affect those trajectories. A special emphasis will be placed on understanding the impact of pre- and postnatal exposure to opioids, marijuana, alcohol, tobacco and/or other substances. To address these broad objectives, the HCAC will oversee study design, development of the common protocol, and monitor recruitment and retention to ensure that the sample of women enrolled includes: 1) a varied cohort that is representative of the US population; 2) pregnant woman with use of targeted substances (opioids, marijuana, alcohol, tobacco); and 3) demographically and behaviorally similar women without substance use in pregnancy to enable valid causal inferences. The HCAC will ensure study objectives are met, monitor performance, provide for training, establish and carry out decision-making and ethical policies, manage all study communications, and oversee processes for considering study modifications. In collaboration with the HBCD Data Coordinating Center (HDCC), the HCAC will ensure that approximately annual study datasets are released to the broader scientific community. The HBCD Consortium Study will inform public policy to improve the health and development of children across the nation. This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.

Public health relevance
The Healthy Brain and Child Development (HBCD) Consortium will follow 7,200 mothers and their children from locations across the United States from before birth to 10 years of age to better understand which harmful and protective environments exert the greatest impact on child development. The HBCD Study will inform public policy to improve the health and development of children across the nation. The HBCD Consortium Administrative Core (HCAC) will provide the leadership and overall management of the consortium to ensure the project’s success.